Coordinating Sustainable Open Resource Sharing and Collaboration in Cancer Research

Abstract The Coordinating Center for the Cancer Systems Biology Consortium and Physical Science in Oncology Network aims to create an annotated repository of the resources generated by the consortia, to disseminate the resources through the Cancer Complexity Knowledge Portal (CCKP), and to motivate collaborations that leverage the reuse of these resources across the consortia and in the larger cancer research community. Through this one-year supplement, the Coordinating Center will continue to collect and annotate resources for the CCKP with a focus on enriching the resource annotations to improve exploration, search, and discovery, and integrating annotations around consortia researchers that will provide links from personnel to resources and information about roles and activities of personnel in the consortia. The Center will also continue to drive collaboration through special interest groups and working groups that engage researchers at different career levels around common scientific themes underlying cancer systems biology. During the next year, there will be an active focus on recruiting early career researchers in these collaborative efforts. Further, tools that support virtual meetings and asynchronous collaboration will be leveraged to maximize opportunities for interactions across the consortia. Finally, there will be a push to increase dissemination of resources and knowledge to the larger scientific community, with the additional aim of targeting communications and outreach to under-represented individuals to improve the diversity of cancer researchers.

Public health relevance
Narrative Advances in cancer research rely on researchers across multiple disciplines sharing their data, tools and knowledge to create a comprehensive picture of underlying mechanisms. This Coordinating Center will support efforts to share and reuse data and tools as well as provide opportunities for researchers to collaborate.